Admin/Coordination Core

ABSTRACT
The goal of the Admin/Coordination Core (ACC) is to provide administrative leadership and to guarantee that all
UCI subunits are interacting and communicating efficiently. Integration with the other consortium members,
Indiana University (IU)/The Jackson Laboratory (JAX)/University of Pittsburgh (Pitt) as well as with Sage
Bionetworks and the National Institute on Aging (NIA) are also key objectives for the ACC. As the leadership
core of UCI MODEL-AD, our goal is to ensure the success of the project by managing and supporting the different
cores in order to develop and characterize novel Late-Onset Alzheimer’s Disease (LOAD) mouse models as well
as to efficiently distribute them to the scientific community. During the past five years, the ACC has successfully
promoted innovative approaches for the generation of new mouse models of Alzheimer’s Disease (AD) by
providing necessary support to the Disease Modeling Project (DMP) Core and the Bioinformatics and Data
Management Core (BDMC) (now called the Functional Genomics and Bioinformatics Data Management Core
[FGBDMC]). Moreover, all mouse models generated during the first iteration of this U54 are now available
through our partner, JAX, with no restrictions to academic and non-academic scientific community; and the data
obtained from the deep phenotyping of these mouse models is publicly available through our partnership with
Sage Bionetworks. The innovative leadership style of the Co-PIs, Drs. LaFerla, Tenner and Green, as well as
their strong experience managing multi-investigator grants, has been a valuable asset to UCI MODEL-AD,
leading to a harmonious and open communication and collaboration among all the core leaders and personnel.
Their continuous interactions with the Steering Committee as well as the External Advisory Board (EAB), via
recurrent meetings organized by the ACC, will help the core leaders to prioritize the generation of new mouse
models and select the most promising ones for a deep phenotyping characterization. As one of the main goals
of U54 is the dissemination of knowledge, the ACC will also coordinate the participation of UCI MODEL-AD in
several international scientific meetings, including those organized by the NIA. In summary, the ACC will play
the key role of being the management engine for this project and will ultimately ensure its success.